EFFECT OF A B2 AGONIST ON MUSCLE MASS IN PROGRESSIVE MUSCLE WASTING DISORDER

The primary objective of this study is to assess the efficacy of albuterol sulfate in the treatment of patients with FSHD. The trial will be a natural history-controlled, open-label pilot study to obtain preliminary results concernign the effectiveness of this agent in FSHD.